Role of alveolar fibroblasts in extracellular matrix organization and alveolar type 1 cell differentiation

ABSTRACT:
An in-depth understanding of the mechanisms that regulate alveolar septation and septal wall maturation will be required
to develop therapies for premature infants with Bronchopulmonary Dysplasia (BPD) and for developing potential therapies
for adult lung regeneration. We and others have begun to define changes in PDGFRa myo, lipo and matrix fibroblast (FB)
function during alveolarization,
homeostasis, regeneration, and fibrosis. Our long-term goal is elucidation of molecular
regulators of FB functions and how diverse FBs support epithelial cells. Our objective herein is to identify molecular mech-
anisms that result in functional changes in alveolar fibroblasts that regulate ECM organization and epithelial differentia-
tion. Integration of transcriptomic datasets predicted GATA6 as a regulator of PDGFRa-FB differentiation. Our preliminary
data show that conditional inactivation of GATA6 in perinatal PDGFRa+ FBs resulted in loss of matrix and gain in lipo fibro-
blast function comparable to findings in BPD and animal models of hyperoxia. GATA6 inactivation in PDGFRa+
FBs also
resulted in fragmented collagen and detachment of AT1 cells from the basal lamina demonstrating a thus far unidentified
role of alveolar FBs in ECM organization. Inactivation of GATA6 resulted in significant increase of the lipo FB transcription
factor TCF21 expression and preliminary in vitro data suggest suppression of TCF21 by GATA6. The central hypothesis is
that GATA6 and transcriptional cofactors regulate FB function in alveolar FBs by suppressing lipo FB differentiation. The
rationale for this research is a new understanding of the regulation of matrix FB function and how these functionally
different stages modify extracellular matrix and the FB-epithelial crosstalk. Aim 1 will test the hypothesis that GATA6
suppresses lipo FB function and promotes ECM deposition in the alveolar FBs. This aim will use lineage tracing to deter-
mine trans-differentiation of the alveolar FB to a lipo FB. And use in vitro cell derived matrices to identify ECM modifica-
tions by lipo and matrix FBs. Aim 2 will test the hypothesis that GATA6 is in a transcriptional network that regulates lipo
and matrix FB function. In this aim we will use in vitro gain and loss of function of GATA6 and TCF21 and identify and
validate transcriptional networks and partnering transcription factors. Aim 3 will test the hypothesis that GATA6 regulates
ECM synthesis and paracrine signaling in PDGFRa+ FBs that direct AT2 to AT1 differentiation. The proposed studies in this
application will identify the transcriptional regulation of matrix FB function and their role in extracellular matrix deposition
and cell-cell signaling in the alveolar niche. The proposed research is conceptually innovative, because we ask questions
regarding the nature of fibroblast plasticity and functional switches. The proposed research is scientifically innovative,
because the contractile function of alveolar fibroblasts, has been thoroughly investigated, but little is known about their
matrix organizing function or
their role in supporting AT2 proliferation and AT1 differentiation This contribution will be
significant because it addresses 1) lack of knowledge of matrix and signaling function of the alveolar FB; 2) identifies and
validates the transcriptional network around GATA6 that regulates FB function.

Public health relevance
NARRATIVE: This proposed research is relevant to public health because it is expected to identify the mechanism(s) that result in maladaptive lung fibroblast differentiation and extra cellular matrix deposition, which can be found in chronic neonatal lung diseases, such as Bronchopulmonary Dysplasia, and adult-onset fibrotic lung diseases, such as idiopathic pulmonary fibrosis. Development of regenerative therapies, leading to restoration of lung structure and function, in chronic lung diseases will need to be guided by insights into the mechanistic underpinnings of defective alveolarization. The proposed research is relevant to the part of NIH’s mission pertaining to developing fundamental knowledge that will inform the upstream regulation and downstream function of matrix fibroblasts with the ultimate objective to restore a microenvironment that is permissive for alveolar repair and allow for better engraftment in cell replacement approaches using iPSC derived cells.